Glial Progenitors as Targets of HIV/Opiate Interactions

DESCRIPTION (provided by applicant): HIV-infected individuals who abuse heroin are at greater risk for HAND. The synaptodendritic injury that underlies HAND is largely mediated by infected and/or activated microglia and astroglia as neurons are rarely, if ever, infected. CNS neurons and glia are derived from neuroepithelial precursors in the subventricular zone (SVZ). In development, undifferentiated, common neural progenitor cells (NPCs) give rise to cells that form neurons, astroglia, and oligodendroglia on a precise schedule of proliferation, migration, and differentiation regulated by complex intra- and extracellular signals. In the mature CNS, neurogenesis is largely limited to specific regions (dentate gyrus and SVZ of lateral ventricles), while gliogenesis also occurs in the parenchyma. During the 1st funding period, we showed that HIV-1 and HIV proteins diminished NPC ability to differentiate and populate the striatum, in mice exposed both perinatally and as adults, and in vitro. In general, HIV R5 (culture) and HIV-1 Tat (in vivo stereology; culture) reduced Sox2+ NPCs and slowed proliferation. HIV-1 Tat in vivo also seemed to redirect cell fate as mature cell populations were changed ( ? oligodendroglia, ? astroglia) while total cell numbers and volume were normal. Co-exposure to morphine exacerbated some outcomes. Thus, both HIV and Tat interfere with NPC development via mechanisms that opiates can amplify. Data demonstrate that R5 or chronic Tat exposure distort normal NPC – microglia interactions, resulting in abnormal CNS populations. Imbalances (? inflammatory ? astroglia, myelinating OLs) likely contribute to HIV-related deficits in CNS function. We hypothesize that HIV by itself, and more potently with morphine, overactivate microglia, causing aberrant signaling to NPCs through NADPH oxidase (NOX2) and iNOS/nitric oxide. The inappropriate signaling misdirects NPC lineage/differentiation, ultimately altering CNS cell populations. This theory is explored in vivo (mouse/HIV-1 Tat model) and in human brain cultures (HIV infective model) in 2 related aims. Aim 1 tests if microglia play a central rol in the aberrant proliferation/lineage of NPCs after exposure to HIV-1 Tat ± opiates. Studies use a macrophage/ microglia deficient transgenic model (HIV-1 Tat x CSF1op/op mice), with chronic Tat induction at both adolescent (high risk for HIV and opiate exposure through exploratory behaviors) and adult stages. Hippocampus and striatum are studied; motor and cognitive behaviors correlated to population changes. NPCs are also examined in HIV+/HIV- autopsy tissue. Aim 2 tests the roles of microglial NOX2 and iNOS signaling as causal in dysregulated NPC dynamics, using 3-dimensional aggregate cultures from human brain and real-time tracking of individual human NPCs±HIV±opiates±specific inhibitors of iNOS, NOX2 and R5 binding. Amnis flow-single cell imaging used to identify infected cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: HIV infection and injection drug use are interlinked epidemics with devastating public health consequences; opioid abuse enhances CNS deficits related to HIV-1 infection. Our previous work suggested that CNS progenitors are dysregulated by exposure to combined morphine-HIV, leading to imbalances of neuron and glial populations that likely affect CNS function. Proposed studies use both HIV protein and infective HIV-human cell models of the disease to determine if chronic opiate-HIV exposure permanently alters cell populations in maturing/adult brains, and the causal role of inflammation/microglia.